LOGISTICS &ADMINISTRATIVE SUPPORT FOR CONFERENCES

The purpose of this contract is to provide logistical and administrative assistance for approximately 38 conferences/meetings over a 3 year period. These proposed conferences/meetings address the concerns and responsibilities of the Division. A number of the meetings and conferences proposed are national and international in scope and are critical to the mission of the Division and Institute.